Kansas Center for Metabolism and Obesity REsearch (KC-MORE) - Human Energy Balance Core

HUMAN ENERGY BALANCE CORE: PROJECT SUMMARY
The Kansas Center for Metabolism and Obesity REsearch (KC-MORE) Human Energy Balance (HEB) core
integrates facilities, equipment, and expertise currently on the University of Kansas Medical Center (KUMC)
campus to support research and training on the prevention and treatment of overweight and obesity and to
evaluate the impact of weight loss on obesity-related co-morbidities in a variety of populations including adults,
children, and in special and underserved populations including individuals with intellectual and developmental
disabilities, physical disabilities, Alzheimer's disease, and in rural residents. The HEB core will include 3
divisions. The Energy Expenditure and Exercise Physiology Division will support assessments of energy
expenditure (laboratory-based and portable indirect calorimetry, stable isotopes, whole-room indirect
calorimetry), body weight (calibrated scales), and body composition (dual energy x-ray absorptiometry, air
displacement plethysmography). This Division will also provide the capability to deliver and document laboratory-
based exercise dosed at specific levels of intensity and energy expenditure and to deliver and monitor both
weight management and exercise inventions remotely to groups of participants in their homes. The Energy Intake
Division will provide assessments of energy, macronutrient and micronutrient intake (direct observation,
weighted and digital image plate waste, self-reports), assessments of biomarkers that are indicators of
compliance to diet recommendations or nutrient absorption, and analysis of the gut microbiome which may play
a role in energy balance. This Division also has the capacity to prepare and serve meals of specific energy and
macronutrient intake for controlled feeding trials. The Clinical Weight Management Division will utilize the
facilities and staff of our on-going KUMC clinical weight management program to provide training, a venue for
pilot research projects, and a mechanism for the delivery of evidence-based weight management interventions
developed by KC-MORE COBRE supported and other investigators. In addition to opportunities for training in
clinical weight management, our clinical weight management program provides a venue to conduct pilot weight
management trials and maintains a registry of data and contact information on over 3,000 previous and current
participants for secondary analysis and pilot surveys. The establishment of the HEB core will centralize, for the
first time on the KUMC campus, the facilities, equipment, expertise, and training opportunities to provide access
to multiple techniques for the assessment of energy intake and energy expenditure suitable for use in weight
management trials conducted in both laboratory and community settings. In addition, HEB core will provide
training in the conduct of weight management trials in both laboratory and community settings using a variety of
strategies for intervention delivery, reducing energy intake and increasing physical activity in adults, children,
and in special and underserved populations.